Homeostatic Plasticity in Mouse Model of Jordan's Syndrome

ABSTRACT
The identification of gene mutations that cause autism and syndromes associated with severe intellectual
disability has greatly advanced both research and new therapeutic development. Yet, the mechanisms that link
gene loss of function to impaired brain function remain poorly understood in almost every instance. There is a
pressing need to elucidate how individual gene mutations lead to deficits in brain function, with the potential to
identify common grounds for therapeutic intervention that will benefit the largest patient population. Recently,
homeostatic plasticity was demonstrated to have a potent ability to counteract neurological disease onset and
progression. This is referred to as Homeostatic Neuroprotection. Based on preliminary data, we propose that
the mechanisms of homeostatic neuroprotection also apply to the onset and progression of impaired
hippocampal function, based on work examining a new mouse model of severe intellectual disability. This work
has the potential to open a new approach toward therapeutic development in psychiatric disease.

Public health relevance
PROJECT NARRATIVE There is a pressing need to understand how gene mutations that confer risk of psychiatric disorders cause neural malfunction. We have generated a model of Jordan's syndrome, a disorder associated with severe intellectual disability. We will build upon preliminary data arguing for a novel intersection of psychiatric disease and adaptive, homeostatic plasticity in the mammalian brain.